Molecular Prediction, Disease Progression, and Type 2 Diabetes (T2D) Phenotypes in South Asians

PROJECT SUMMARY
Type 2 Diabetes (T2D) and prediabetes are characterized by substantial heterogeneity. Evidence indicates that
T2D is comprised of several phenotypic subgroups with diverse clinical characteristics, disease progression,
treatment responses, and risks of complications. Nevertheless, significant gaps persist in our understanding of
the biological underpinnings, molecular mechanisms, and translational implications of T2D phenotypes,
particularly in non-European populations like South Asians. This population is at high risk for both T2D and
prediabetes and exhibits unique phenotypic manifestations. In our preliminary investigations, we demonstrated
that, unlike Europeans, where insulin resistance primarily drives the pathophysiology, South Asians present a
notably higher prevalence of mild and severe insulin deficient T2D phenotypes (79%). Most significantly, these
phenotypes were found to be responsible for ~ 82% of diabetes-related mortality cases. Additionally, among
participants with prediabetes, 64% showed the attributes of an insulin deficiency phenotype, contributing to
~74% of incident diabetes cases. Currently, uncertainties remain regarding genetic patterns distinguishing
prediabetes and T2D phenotypes and the predictive potential of genetic or metabolomic factors in the
progression to T2D. To address these gaps, we propose leveraging the NHLBI-funded PPG, the Precision-
CARRS cohort (P01HL154996), consisting of ~20,000 individuals with over 13 years of follow-up and banked
biospecimens, including 6,237 T2D and 8,381 prediabetes cases. Our aims are to: (Aim-1) Investigate genetic
associations with T2D and prediabetes phenotypes, develop polygenic risk scores, and explore the
associations between genetic factors and glycemic trajectories; (Aim-2) Assess associations of metabolomic
markers and develop metabolite scores using a high-resolution untargeted approach and examine their
relationship with glycemic trajectories; (Aim-3) Evaluate the predictive utility of genetic variants and plasma
metabolites, in conjunction with traditional diabetes risk factors, for distinguishing incident T2D cases. We will
also assess the predictive utility of the identified genetic and metabolomic markers with the incident
cardiovascular outcomes. This project will facilitate significant progress in translational precision medicine and
public health, deepening our understanding of the intrinsic genomic and phenotypic heterogeneity that
underlies novel T2D and prediabetes phenotypes in this under-represented high-risk population. Through
these efforts, we will advance the prevention and management of prediabetes and T2D, leading to
personalized and precise disease prediction and early-stage detection.

Public health relevance
PROJECT NARRATIVE Type 2 Diabetes (T2D), characterized by significant heterogeneity, presents substantial gaps in molecular understanding, particularly among non-European populations, such as South Asians. We will leverage the ongoing Precision-CARRS cohort and the banked biospecimen to investigate the molecular (genomics and untargeted metabolomic markers) associations of prediabetes/T2D phenotypes and glycemic progression in South Asians and to evaluate the predictive utility of integrating genetic and metabolite information to assess incident T2D and cardiovascular risk among individuals of South Asian ancestry. Thus, we aim to advance the prevention and management of prediabetes/T2D toward personalized and precise disease prediction, as well as early detection.